Boston University Rheumatology Research Training (BURRT) T32 Program

The Boston University Rheumatology Research Training (BURRT) T32 Program is a new application
leveraging a prior two-decade history of providing outstanding training to physicians and scientists in clinical
investigation of the epidemiology, management, and outcomes of rheumatic and musculoskeletal diseases.
The BURRT T32 Program will leverage numerous institutional programs and broaden the T32 faculty
mentoring pool to include new disciplines to better prepare postdoctoral T32 MD and PhD scholars for careers
in clinical research in academia and industry. The objectives of the program are to graduate 3 postdoctoral T32
scholars every 2 years in our multidisciplinary program, with an emphasis on recruiting and retaining scholars
from underrepresented in medicine (URiM) backgrounds. We will train them to succeed in becoming
independent clinical researchers in rheumatic and musculoskeletal diseases transitioning to their first faculty
position or research-related job outside of academia. We will provide a strong foundational Core Curriculum in
epidemiology, biostatistics, and clinical research methods with project-based team mentoring and numerous
avenues for career and professional development. We will additionally provide broad multidisciplinary training,
including coursework, that provides additional training in one or more specialized tracks selected by the T32
scholar: 1) Health Disparities and Community Engagement; 2) Bioinformatics, Genomics, and Machine
Learning; 3) Behavioral Interventions and Mobile Health Technologies; 4) Implementation Sciences. The
program aims to address key areas identified through a needs assessment to better prepare post-doctoral T32
scholars for engaging in cutting-edge clinical research with more in-depth exposure to newer areas of research
disciplines and methods. Each T32 scholar will be carefully matched to an appropriate team of experienced
and funded mentors to provide expert research guidance, career guidance, and professional development,
aided by an individual development plan (IDP). We will evaluate each component of the training program
formally and comprehensively. A key foundational aspect to the program is a weekly multidisciplinary clinical
research meeting. The program additionally includes required coursework, opportunity to pursue a Master's
level degree, and attendance at a broad array of seminars and hands-on experiences in each of the Tracks,
cross-program and trans-institutional networking opportunities, industry and journal roundtables and
internships, IRB internship, journal clubs, and career counseling, among others. Trainees will develop
professional skills in writing grants, scientific manuscripts, oral presentations, and undergo training in the
responsible conduct of research, enhancing reproducibility in research, team science, and leadership and
industry collaborations. Overall, the program is designed to prepare the future leaders in rheumatic and
musculoskeletal diseases clinical research.

Public health relevance
The Boston University Rheumatology Research Training (BURRT) T32 Program will provide a comprehensive two-year multidisciplinary training program in rheumatic and musculoskeletal diseases for postdoctoral MD and PhD scholars to pursue academic and scientific clinical research careers. The program will train 3 postdoctoral scholars every 2 years in a core curriculum and several specialized tracks under the guidance of experienced and funded mentors, and supported by a broad curriculum with coursework, seminars, roundtables, team research meetings, and hands-on experiences. Ultimately, the program aims to have T32 scholars successfully transition to independent clinical research careers as the next general of leaders in rheumatic and musculoskeletal disease research.